Administrative Core

Abstract: The Administrative Core is responsible for overall operations of the Rochester Environmental Health Sciences Center (EHSC) and is a focal point for Center activities. The main roles of the Administrative Core are coordinating all Center components, fostering collaboration, promulgating new research directions and esprit de corps, evaluating progress, stimulating improvements, allocating budgets and overseeing expenditures, and maintaining routine operations. The administrative structure of the Center promotes and supports maximal and effective communication and coordination among all of the Center components. This configuration integrates and enhances multi-directional research, community engagement, and effective and open communication, and supports all Center activities. The two central components of the EHSC Administrative Core are its Personnel and Programs. Personnel include the Director, Deputy Director, Career Development Program director, Administrative Staff, as well as members of the Internal and External Advisory Committees. Programs encompass the Career Development Program, monthly meetings of all Center members, monthly meetings of the Internal Advisory Committee, the Center Seminar Series, and website. Spanning across all of these people and programs are interactions with the Integrated Health Sciences Facility Core (IHSFC), Community Engagement Core, Biostatistics Core and Pilot Project Program. The Administrative Core also maintains the connectedness of the EHSC across the University of Rochester, with other NIEHS Centers, the NIEHS, and also with local, national and international community stakeholders and partners. Thus, the Administrative Core supports the overarching goals of the Rochester EHSC, which are to prevent disease and improve health by advancing innovative and impactful translational environmental health research, engaging communities to address environmental health issues, and enhancing career development of talented environmental health investigators.